Perfecting tools to define the glycan-protein interactome

Glycans, sugar structures on glycoproteins and glycolipids, are abundant on cell surfaces where they regulate
cell physiology, often by interacting with glycan-specific binding proteins. Deciphering the “glycan code” of cell
regulation is a key goal for glycobiology with great potential to impact human health in many clinical areas
including cancer diagnosis and therapy, immune system disorders, and nervous system diseases. This “Focused
Technology Research and Development” application, based on recent advances by our team, merges bioortho-
gonal chemistry and deep learning tools to experimentally and computationally explore the glycan interactome.
Our approach focuses on a subset of the human glycome, gangliosides, which offer great technical advantages
for these efforts. Gangliosides, sialic acid-bearing glycans carried on ceramide lipids, are embedded in the outer
leaflet of the plasma membrane of all human cells with their glycans facing outward. They function in diverse
regulatory pathways involved in cell-cell adhesion, signal transduction, and ion transport. Ganglioside expression
is linked to human diseases including cancer, diabetes, neurodegeneration, and infectious diseases. As probes
of the glycan interactome they have the great advantage of being “stand-alone” functional units, each with a well-
defined glycan structure. They are chemically accessible and readily deliverable to live cells. We capitalized on
these properties to synthesize proof-of-concept bifunctional ganglioside probes bearing photoaffinity diazirines
and click alkyne tags. We delivered these to human cancer cell lines, captured their ganglioside-protein
interactome, and characterized it by proteomic mass spectrometry. The next phases of technology development
constitute the focus of the current application.
Aim 1: Human gangliosides are quantitatively dominated by just eight glycan structures, each carried on a
ceramide lipid. Our proof-of-concept study focused on three of these (GM3, GM1, GD1a) representing a range
of glycan sizes. Each was derivatized individually with minimally disruptive bifunctional diazirine-alkyne tags on
the ceramide lipid, the sialic acid, and (where feasible) the terminal galactose. The current proposal extends the
repertoire and scale of synthesis to embrace cancer-associated gangliosides GM2, GD3, and GD2 and major
brain gangliosides GD1b and GT1b, completing the eight-ganglioside set. These will be validated using human
cancer and neural cells. The outcomes will be used to evaluate and optimize deep learning computational tools
designed to independently identify glycan-protein interactions.
Aim 2: Gangliosides with bifunctional probes installed on their glycan sialic acid moiety capture proteins via a
covalent bond to each protein’s glycan binding site. Subsequent protein depolymerization, tagged peptide
capture, and release for mass spectrometric identification will allow us to catalog glycan binding sites
simultaneously on numerous glycan-interacting proteins in a single experiment. The sites will be computationally
compared to deep learning all-atom models optimized for glycan-protein binding.

Public health relevance
Glycans, sugar structures carried on glycoproteins and glycolipids, are abundant on cell surfaces where they regulate cell health via interaction with glycan-specific binding proteins. Deciphering the “glycan code” of cell regulation is a key goal for glycobiology that has great potential to impact human health in clinical areas including cancer diagnosis and therapy, immune system disorders, and nervous system diseases. This focused Technology Research and Development application combines the power of chemistry and deep learning computation to the identification and structural determination of glycan-protein interactions.